CHARTING THE EPIGENOMIC LANDSCAPE OF HUMAN TRANSPOSABLE ELEMENTS

DESCRIPTION (provided by applicant): We propose to develop novel computational methods to identify regulatory elements in repetitive regions of the genomes using publicly available data from Roadmap Epigenomics and ENCODE. Half of the human genome is derived from transposable elements (TEs). These highly repetitive elements were recently shown to harbor transcription factor (TF) binding sites and epigenetic regulatory signals. TEs have shaped gene regulatory networks during evolution and are dysregulated in many diseases. However, the extent to which TEs contribute to regulatory networks, and how TE sequences evolved from parasitic DNA to functional elements, remains unclear. In this proposal, we introduce a computational framework to identify TE-derived cell type-specific enhancers and to estimate the evolutionary impact of TEs to cell type-specific gene regulation. In Specific Aim 1 we plan to develop an epigenomics-based approach to detect TE-derived enhancers and their target genes. Extending our recent success in developing machine learning methods to integrate DNA methylation data, we will bring to bear computational models that allow us to predict TE-derived enhancers. If successful, not only will we produce the largest catalog of TE-derived cell type-specific enhancers, but also have created a robust framework for detecting the contributions of TEs to gene regulation in any cell type or tissue. In Specific Aim 2 we will develop a TE epigenetic association assay. By taking advantage of the multi-copy nature of TE sequences, we will identify TE sequence variations or features that associate with specific epigenetic and/or TF binding pattern. We will reconstruct sequences of the evolutionary intermediates of candidate TEs and estimate their epigenetic and/or TF binding pattern. We will address questions including whether particular classes of TEs gained TF-binding sites and then spread quickly, or whether TEs first spread and later gained TF binding sites. If successful, we will develop an understanding of what sequence features drive the functional potential of TEs, and the modes of evolution followed by different TEs during regulatory network evolution. Such an understanding will dramatically improve our picture of regulatory network evolution by including the effects of TEs, a major class of fast evolving regulatory sequences that have been largely ignored in functional genomics studies. In Specific Aim 3 we will create a public resource based on our newly invented Repeat Element Browser to allow investigators to display, analyze, compare, and integrate Roadmap/ENCODE data and their own data on TEs. The methods developed in this proposal will have a high impact on the utility of data produced by consortia such as ENCODE, Roadmap Epigenomics, and TCGA, which currently discard most TE derived sequences. Such improvement will in turn accelerate research into understanding the impact of TEs on normal gene regulation and in human diseases.

Public health relevance
PUBLIC HEALTH RELEVANCE: Transposable elements (TEs) are a special class of DNA sequences which copy themselves and "hop" to many different locations in the genome. TEs are often referred to as "junk" DNA or "parasitic" DNA, but they are more and more implicated in genome evolution, gene regulation and diseases. These elements comprise a huge fraction of the DNA in mammalian genomes, including 50% of the human genome. Because of their repetitive nature they are generally discarded in most genomics studies. We recently showed that these elements often carry regulatory sequences that are co-opted by host genomes to perform normal gene regulation. Here we propose to study the extent to which TEs contribute to normal gene regulation throughout the genome and how mis-regulation of TE derived sequences contributes to disease.